A culturally tailored, scalable asthma intervention for Mexican American children

Project Summary
Mexican American children are the only demographic group whose asthma prevalence is increasing and
Mexican American children with asthma have a ~2-3-fold greater risk of being hospitalized than their non-
Latinx white counterparts. This excess burden of morbidity affects the ~ 200,000 Mexican American children
with asthma in Texas. Thus, we propose to develop and pilot a scalable, culturally-tailored, multilayered
asthma intervention, Asma Guardián, designed to reduce asthma morbidity among Mexican American
children. Asma Guardián will be modeled on efficacious community-based asthma interventions and will
include three “tool kits”: (1) support for accessing asthma specialist care, (2) asthma management education
and support, and (3) home environment education, access to housing advocacy services, and access to
environmental intervention supplies. Asma Guardián will be developed in partnership with Mexican American
children with asthma and their parents and will be grounded in communication and behavioral science to
maximize engagement. The primary objectives of the project are 1) To develop Asma Guardián, a culturally-
tailored asthma intervention that facilitates access to asthma specialist care and provides education and
support for asthma self-management and home environmental interventions and 2) To conduct a pilot trial to
inform the planning of a state-wide trial of Asma Guardián. The proposed work is both necessary and
sufficient to inform the planning of a state-wide trial of Asma Guardián, which will be the first scalable,
culturally-tailored asthma intervention for Mexican American children and will serve as a model for delivering a
population-scale intervention.

Public health relevance
Project Narrative Asma Guardián will be among the first Mexican-American-tailored, community-based asthma intervention that is designed to scale to the state-level, can be launched by any entity and designed to empower families to engage in three actions that are known to improve asthma outcomes. We will pilot test Asma Guardián and will have multi-dimensional data on engagement and process measures as well as an estimate of its effects on asthma outcomes, including asthma control and exacerbations. Completion of the proposed aims will strongly position the investigator team to successfully plan and execute a state-wide trial of Asma Guardián.